An animal model of anti-AQP4 autoimmunity

A pathogenic immune response targeting aquaporin-4 (AQP4) causes neuromyelitis optica spectrum disorder
(AQP4 NMOSD), a disabling neurological illness that leads to blindness and paralysis. Recent advances in
treatment for AQP4 NMOSD have improved its prognosis but are associated with increased risk of serious
infections. As an autoimmune neurological illness with a well-defined autoantigen, AQP4 NMOSD should be
amenable to a cure by antigen-specific ablation or tolerization. However, preclinical testing of antigen-specific
tolerizing therapy for AQP4 NMOSD remains hampered by the lack of an animal model that recapitulates the
autoimmunity and the pathology in the same animal. Current animal models of AQP4 NMOSD require adoptive
transfer which introduces confounding variables that are difficult to resolve. The objective of this proposal is to
develop a model that recapitulates the autoimmunity and the pathology of AQP4 NMOSD in the same animal
and thereby develop an animal model suitable for preclinical testing of antigen-specific tolerization therapies.
Aim 1.1 will establish anti-AQP4 autoimmunity in the AQP4 null (AQP4.lacZ) mouse. Aim 1.2 will test two
methods to restore AQP4 expression in the AQP4.lacZ mouse: 1) AAV-mediated AQP4 transduction and 2)
inducible (tamoxifen) and conditional (GFAP promoter) Cre recombinase system to restore AQP4 expression in
the AQP4.lacZ mouse. Aim 1.3 will test the hypothesis that restoring AQP4 expression following immunization
against AQP4 in the AQP4 null mouse will result in AQP4-directed autoimmunity and pathology in the same
animal. The successful completion of the proposed research is expected to deliver a new animal model that
more fully recapitulates the autoimmunity and the pathology of AQP4 NMOSD, and thereby overcome the
shortcomings of the current models. Once this model is developed, it will make a positive impact by facilitating
preclinical studies aimed at developing antigen-specific ablation/tolerization therapies as cure for AQP4
NMOSD.

Public health relevance
Project Narrative This research addresses neuromyelitis optica spectrum disorder (NMOSD), a disabling autoimmune neurological illness that can result in blindness and paralysis. The purpose of the research is to develop an improved animal model suitable to test new therapies for NMOSD. Successful completion of this research project is expected to make a positive impact by contributing to the discovery of a cure for NMOSD.